Molecular Mechanism of Eosinophil Cell Death

DESCRIPTION (provided by applicant): Cell death is essential for many physiological processes, and its deregulation characterizes numerous human diseases. Thus, in-depth investigation of cell death and its mechanism has tremendous implications for the development of novel therapeutic strategies. This is especially true for eosinophils, whose extended survival and activation or necrotic cell death with release of toxic granule proteins lead to tissue inflammation in eosinophil-associated diseases. Classically, cell death was divided dichotomously into apoptotic and necrotic; however, recent studies have suggested the existence of a continuum of cell death phenotypes, as well as novel, distinct cell death processes such as regulated necrosis and, in certain situations, autophagy. Importantly, these subtypes are differentially regulated by specific biochemical cascades; thus, the correct identification of cell death phenotype may have important therapeutic implications, as cells may be targetable by regimens that induce or inhibit a specific mode of cell death. Regulated necrosis commonly occurs in situations in which cells receive a cell death signal but apoptosis is inhibited (e.g. Fas ligation concurrent with caspase inhibition). Similarly, we observed the paradoxical enhancement of cell death in eosinophils simultaneously treated with survival factors (e.g. IL-5, acidity) and cell death-inducing agents (anti-Fas, anti-Siglec-8). Moreover, th mode of cell death was distinct; anti-Siglec-8 induced caspase-dependent apoptosis whereas anti-Siglec-8 in IL-5-treated eosinophils caused caspase- independent cell death. Conceptually, these findings are consistent with the notion that in the tissue microenvironment, eosinophils are exposed to multiple signals simultaneously, including pro-survival and pro- cell death signals. Indeed, in tissue samples collected from patients with eosinophilic inflammatory disease, a large portion of eosinophils display ultrastructural characteristics of cytolysis or necrosis. However, the spectrum of cell death phenotypes induced in eosinophils and the biochemical mechanisms leading to these modes of cell death are not known. The studies proposed in this grant application aim to address this gap in knowledge and to serve as a platform for the eventual translation of this knowledge to clinical settings. Our central hypothesis is that eosinophils undergo regulated necrosis, a targetable process, which has important pathophysiological implications in eosinophil-associated disease. We propose two specific aims to test this hypothesis: 1) to define the spectrum of human eosinophil cell death phenotypes, and 2) to determine the pathophysiological consequences of regulated necrosis of eosinophils. We will use innovative approaches in primary human eosinophils, biopsies from patients with eosinophilic disease, and animal models. Our studies will provide proof-of-concept that regulated necrosis occurs in eosinophils (aim 1) and that it is significant in disease (aim 2), which will provide critical preliminary data for a mechanistic R01-level grant application.

Public health relevance
PUBLIC HEALTH RELEVANCE: Despite intense research and significant advances in clinical care, asthma and eosinophilic gastrointestinal disorders are not well controlled in a large subset of patients resulting in significant morbidity and cost. Exploring pathways to dampen disease pathogenesis in human cells can be extremely useful in the development of new therapeutic agents. Clinical studies with anti-IL-5 strongly suggest that eosinophils play a critical pathogeni role in many patients with asthma and eosinophilic disorders. Experiments in this application will dissect the mechanisms by which eosinophil viability is regulated in disease, which would be expected to provide critical knowledge that will lead to favorable clinical benefits for those with asthma, allergic diseases and eosinophilic gastrointestinal disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Cell death is essential for many physiological processes, and its deregulation underlies the pathogenesis of many human diseases. Thus, in-depth investigation of cell death and its mechanisms has tremendous implications for the development of novel therapeutic strategies. This is particularly true for eosinophil-related diseases as eosinophils are end-stage cells with no proliferative capacity, and regulation of their survival versus cell death is a key checkpoint for their activation and involvement in disease pathogenesis. Typically, cell death was dichotomously classified as either "apoptotic" or "necrotic"; however, recent studies have suggested a "continuum" of cell death phenotypes, as well as novel, distinct processes such as regulated necrosis. Importantly, these processes are differentially regulated by specific biochemical cascades; thus, the correct identification of cell death phenotype may have important therapeutic implications, as cells may be targetable by regimens that induce or inhibit a specific mode of cell death. Regulated necrosis (a.k.a. programmed necrosis or necroptosis) commonly occurs in situations in which cells receive a cell death signal but cannot undergo apoptosis (e.g. Fas ligation concurrent with caspase inhibition). For example, we have observed the paradoxical enhancement of cell death in eosinophils simultaneously treated with survival factors (e.g. IL-5, acidity) and cell death-inducing agents (anti-Fas, anti-Siglec-8). Moreover, the "mode" of cell death was distinct; anti-Siglec-8 induced caspase-dependent apoptosis, whereas anti-Siglec-8 in IL-5-treated eosinophils caused caspase-independent cell death. Conceptually, these findings are consistent with the notion that in the tissue microenvironment, eosinophils are exposed to multiple signals simultaneously, including pro-survival and pro-cell death signals. Indeed, in tissue samples collected from patients with eosinophilic inflammatory disease, a large portion of eosinophils display ultrastructural characteristics of cytolysis or necrosis.1-3 However, the spectrum of cell death phenotypes induced in eosinophils and the pathophysiological consequences of these modes of cell death are not known. The studies proposed in this grant application aim to address this gap in knowledge and to serve as a platform for the eventual translation of this knowledge to clinical settings. Our central hypothesis is that eosinophils undergo regulated necrosis, a targetable process, which has important pathophysiological implications in eosinophil- associated disease. We propose two specific aims to test this hypothesis: Aim 1. Define the spectrum of human eosinophil cell death phenotypes. This aim will test the hypothesis that eosinophils undergo different forms of cell death, including regulated necrosis, depending on the signals received. We will treat human eosinophils with a combination of pro-survival and pro-cell death signals. We will assess the distribution of viable cells and cells undergoing apoptosis, necrosis, and regulated necrosis by biochemical, pharmacological, and morphological characteristics. We will also extend these findings to tissue eosinophils by testing the hypothesis that eosinophils present in tissue biopsies from patients with eosinophilic gastrointestinal disorders (EGID) undergo different modes of cell death. We will assess for modes of tissue eosinophil cell death in fresh biopsies as well as following culture of the biopsy specimens with cell death- modulating factors. Aim 2. Determine the pathophysiological consequences of regulated necrosis of eosinophils. Inhibiting necrosis could either improve (e.g. via eosinophil apoptosis and non-inflammatory removal of cells) or worsen outcomes (e.g. via long-lived activated eosinophils). This aim will test the hypothesis that inhibiting regulated necrosis of eosinophils will improve outcomes in eosinophilic disease. We will determine the pathophysiological importance of regulated necrosis in a mouse model displaying necrotic cell death during eosinophilic inflammation. Regulated necrosis will be inhibited by pharmacologic and genetic approaches. The overall goal of this grant application is to identify mechanisms to mitigate destructive eosinophil cell death. Simplistically, both alive and dead eosinophils can lead to positive and negative outcomes (Fig. 2). For instance, eosinophils are present in some tissues during homeostasis with no ill effect (upper left, Fig. 2), presumably restrained in part by signaling through inhibitory receptors such as SIRP-α and CD22.4,5 During eosinophilic inflammatory diseases, eosinophils display an activated phenotype and lead to tissue destruction (upper right, Fig. 2). Homeostatic or inflammatory eosinophils may die a silent death by either apoptosis or egress from tissue (lower left, Fig. 2). However, in many diseases eosinophils die a destructive death (lower right, Fig. 2). This grant application focuses on characterizing the different types of eosinophil cell death, with the goal of preventing the destructive forms and encouraging the silent forms of cell death. The recent advancements in pharmacology and cell biology of regulated necrosis, coupled with our expertise in eosinophil biology as it relates to cell death ! and disease pathogenesis, make this grant application timely, innovative, Figure 2. Conceptual framework of and significant. Importantly, results from these studies will provide proof- eosinophil cell death (vertical axis) and of-concept that regulated necrosis occurs in eosinophils (aim 1) and is its affect on disease outcomes significant in disease (aim 2), which will serve as critical preliminary data (horizontal axis). This grant will focus on the red-circled process. for a mechanistic R01-level grant application. !